Longitudinal imaging of stem cell coordination and cross-regulation in the testis niche

Proper function of the Drosophila testis and consistent production of sperm requires exquisite coordination between two resident stem cell populations—the germline stem cells (GSCs) and the somatic Cyst Stem Cells. Germ cell differentiation requires that every one GSC daughter (a gonialblast, or Gb) is completed encased or encysted by precisely two daughters of the Cyst Stem Cell lineage. The testis niche coordinates production of daughter cells from these two stem cell populations by imposing a cytokinetic delay on the GSCs and requiring cell contact with encysting cells in order for abscission, the final step of cytokinesis, to be triggered. Interestingly, there is significant variability in the length of the cytokinetic pause (30 to 75% of the cell cycle). For the system to achieve robustness with a three-cell unit consistently formed, the variability in pause length suggests that the pause, encystment and trigger must be capable of each compensating for changes in timing of the other steps. This predicts substantial cross- talk between the two stem cell lineages to monitor proliferation rates, stem cell numbers and cytokinesis timing. Prior studies revealed only a small degree of coordination in proliferation in the niche. In fact, our analysis showed a lack of any significant mitotic synchrony between GSCs and their flanking CySCs and no evidence that CySCs flanking the same GSC were mitotically coordinated. Thus, we hypothesize that it is not mitosis, but modified GSC cytokinesis combined with cross-talk and monitoring of daughter cell numbers between the two stem cell populations, that generates a robust system to coordinate daughter cell release from the niche. Our feedback model predicts that defects in cytokinesis timing would affect proliferation while changes in proliferation or stem cell number would affect cytokinesis timing. Here, we will directly assess the degree of coordination between Gb encystment and abscission by simultaneous imaging of both stem cell populations. We will then determine the degree of co- regulation and cross talk between the two stem cell lineages to identify the underlying mechanisms that ensure a robust outcome

Public health relevance
Project Narrative The goal of this project is to understand the molecular mechanisms by which a specialized niche environment controls and coordinates production of daughter cells from multiple resident stem cell populations. We focus on the fruit fly testis as a model system and through long-term live imaging of the intact niche combined with genetic manipulations we interrogate how the niche modifies an essential cellular process—cytokinesis—in one stem cell lineage to ensure coordinated release of daughters from two distinct stem cell types. Defects in modified cytokinesis and loss of coordination between stem cells leads to tumorigenesis and tissue degeneration, making it essential to understand the cell biology of stem cell coordination to gain insight into how this process becomes misregulated with disease.